Core A - Administrative and Biostatistics Core

PROJECT SUMMARY – CORE A
The Administrative and Biostatistics Core (referred to as Core A). Core A has two interrelated
components: Administrative and Biostatistics, which serve to advance the missions of the P01 that
are not able to be served by other entities. The overriding objectives or Specific Aims of the
Administrative component, under the direction of Dr. Anil Rustgi (also overall Director of Core A), is
to coordinate an integrated research program between the Projects and with strong support from the
scientific Cores. This Administrative component also facilitates interactions with Penn's Perelman's
School of Medicine, its NCI designated Abramson Cancer Center, external institutions, enrichment
programs, career development pathways, catalyzes new directions for our P01, and ensures that the
P01 has the unequivocal and wholehearted institutional support. The Biostatistics component, under
the direction of Dr. Qi Long, Professor of Biostatistics, is located in the Penn Center for Clinical
Epidemiology and Biostatistics (CCEB). Its objectives or Specific Aims are to provide
comprehensive support for the Projects in experimental design, statistical modeling/analysis, data
interpretation and methodological investigations. In aggregate, this Core enables innovative basic
science research with translation of robust preclinical models into new perspectives in therapeutics
of esophageal cancer, which is a major gap in the field.